Implementing a multistage optimization strategy to identify the best combination of program adaptations to promote breastfeeding at the Lummi Indian Reservation

ABSTRACT
The overall goal of this K01 award is to support Dr. Long in becoming an independent investigator specializing
in the use of cutting edge implementation methods to address health inequities and improve the health of birthing
parents and infants. The focal point of the proposed research is to adapt an existing national breastfeeding
program to improve breastfeeding initiation and duration in American Indian and Alaskan Native (AI/AN)
communities. Breastfeeding provides enormous immediate and long-term health benefits for both infants and
birthing people, reducing the risk of obesity, diabetes, and death in children, and cancer, diabetes, and
cardiovascular diseases in birthing people. However, there are important racial and ethnic disparities in
breastfeeding rates in the United States, and AI/AN communities are both less likely to breastfeed and are at
greater risk for many of the adverse health outcomes that breastfeeding protects against. This proposed research
will use methods grounded in community engagement and health equity to assess barriers to breastfeeding
among AI/AN residents at the Lummi Indian Reservation, and then test adaptations designed to address those
barriers and improve breastfeeding uptake and duration. The proposed work will use a novel optimization design
that will allow for multiple strategies to be tested and will place priority on both efficacy and cost of program
adaptations. The specific aims of this proposal are: 1) to assess barriers to breastfeeding in Lummi parents and
identify adaptations to the existing promotion program to address those barriers; 2) to test adaptations to the
program to identify an optimal adapted program; and 3) to determine acceptability, appropriateness, and
feasibility of the adapted components. This proposed work has been designed to address a key public health
priority identified by leadership at Lummi Tribal Health Center, and the work will be carried out in partnership
with Lummi Tribal Health Center leaders and in collaboration with a community advisory board.
These research aims are one aspect of a comprehensive training plan designed in coordination with an
exemplary interdisciplinary mentorship team. Dr. Long will receive mentorship, training, and coursework in
implementation science, community-based participatory research, and integration of health equity into research
design. The specific training goals of this proposal include 1) gaining proficiency in the use of implementation
science frameworks; 2) learning and applying advanced implementation science study designs; and 3) learning
to conduct ethical equity-focused implementation research. The final goal is to provide Dr. Long with mentorship
and support in career development, and this research and training plan will provide opportunities to publish
original research, present at conferences and workshops, and gain visibility within her field. The resulting data
from the proposed research will provide the basis for an R01 application to test and scale the findings through a
randomized controlled trial. This proposed work will build on Dr. Long’s existing expertise in epidemiology and
implementation science, and provide the training, experience, and data for her to transition to independence.

Public health relevance
PROJECT NARRATIVE Breastfeeding provides enormous health benefits to birthing parents and children, but rates remain disproportionately low among populations who are at greatest risk for adverse children’s health outcomes, including American Indian and Alaskan Native (AI/AN) communities. This proposed work addresses this critical gap by using community-centered methods to identify barriers to breastfeeding at Lummi Indian Reservation and adapting the existing breastfeeding promotion program to make it more culturally responsive. This research will assess efficacy, cost, and feasibility of program adaptation, and will provide preliminary data for a randomized trial to scale adaptations in AI/AN communities that rely on the same national breastfeeding promotion program.